ARTERIOVENOUS DIFFERENCES IN PLASMA NICOTINE CONCENTRATIONS

The goal of this study is to investigate the effects of nicotine administered by three different routes (cigarette smoking, nicotine nasal spray, intravenous nicotine) in smokers.